Northwestern University Infectious Diseases Education and Science (NuIDeas)

Project Summary
This resubmission application requests a third cycle of support for the Northwestern University Infectious
Diseases Education and Science (NuIDeas) Training Program. The goal of this program is to take advantage
of the clinical and basic research expertise and resources available at Northwestern University to train MD and
MD/PhD fellows in infectious disease translational research. This training program leverages the considerable
clinical expertise of the Infectious Disease faculty with the long-standing basic science strengths in
microbiology and immunology at Northwestern University, which together create a rich environment for
translational research. Each trainee works with both a primary research mentor and a clinical co-mentor to
enhance the translational aspects of the fellow's research experience. Excellence in research will be promoted
by a training program consisting of an intensive research experience, the option to obtain a Master of Science
degree in Clinical Investigation, seminars, career development programs, and education in the ethical conduct
of research. One highly qualified MD or MD/PhD fellow is chosen each year for a two-year intensive research
experience. Furthermore, the Feinberg School of Medicine has funded a second trainee slot, such that a total
of two new trainees have been and will continue to be enrolled into the program each year. To date, the
NuIDeas Program has been highly successful. Eleven fellows were appointed to the NIH-funded slots. Of the
nine who have finished training in NuIDeas, seven now hold academic infectious disease appointments, five of
which have protected research time. During the third cycle of funding, we propose several innovations,
including a multifaceted focus on diversity, the addition of a novel research training exercise to bridge bedside
to bench discoveries, an apprenticeship program to train the next generation of NuIDeas leaders, a post-
NuIDeas program to provide an additional year of research training, and an expansion of the panel of mentors
to better match research opportunities to the interests of the fellows. This program will position trainees to
assume leadership positions in research and education at a critical time during which COVID-19 and other
global infectious disease threats are coupled with a shrinking pool of infectious disease subspecialists.

Public health relevance
Project Narrative The continued emergence of new pathogens such as SARS-CoV-2, the unacceptable morbidity and mortality due to conventional infections, and the epidemics of antibiotic-resistant bacteria highlight the need for well- trained researchers in infectious diseases. This postgraduate training program in infectious diseases will provide training for investigators capable of harnessing the discoveries in the basic sciences of microbiology and immunology to develop novel interventions aimed at ameliorating the burden of infectious diseases.